Aging and Mechanisms of Aging-Related Disease

ABSTRACT Support is requested for a Keystone Symposia conference entitled Aging and Mechanisms of Aging-Related Disease, organized by Drs. Kazuo Tsubota, Shin-ichiro Imai, Matt Kaeberlein and Joan Mannick. The conference will be held in Yokohama, Japan from May 15-19, 2017. Populations are aging rapidly worldwide, particularly in Asia, driving a strong interest in aging/longevity research. This conference will capture the cutting-edge front of this exciting field of science, covering essential aspects of aging/longevity research, including critical signaling pathways and regulators, inter-tissue communication, stem cells, stress and damage responses, cellular senescence, physiological rhythms, human genetics and mental well-being (happiness). Because aging is a systemic phenomenon, it is important to address various layers of the aging/longevity- controlling hierarchy, particularly focusing on metabolic regulation, including mitochondria, NAD+, oxidative stress, inflammation, protein homeostasis, autophagy and many other age-associated pathophysiologies. The outcome of these studies needs to be translated to resolve social and economic issues caused by rapidly aging societies. Novel therapeutic and preventive interventions have been explored and developed as a growing attempt to meet the needs of our aging societies. These new aspects of aging/longevity research and the gaps in knowledge between the basic science and practical applications will also be covered in the conference. There is a growing body of evidence that our modern lifestyle, such as the heavy use of blue light in smart phones and tablet computers, affects physiological rhythms and metabolism, promoting age- associated diseases such as obesity, diabetes, cancer and depression. Therefore, it is now time to think differently about what we can do to deal with all these problems in light of recent progress in this exciting field of science.

Public health relevance
PROJECT NARRATIVE Nearly every developed country in the world is seeing unprecedented increases in the numbers of elderly citizens. This demographic shift is dramatically increasing the incidence of aging-related diseases, causing an increasing healthcare burden in these countries. The Keystone Symposia conference on Aging and Diseases of Aging aims to address the urgent need to understand the mechanisms of aging and thereby develop new interventions that target aging-associated functional decline and aging-related diseases.